Genome Architecture and Gene Control in Response to Stress

Genome Architecture and Gene Control in Response to Stress
The 3D topology of the genome plays a critical role in transcriptional regulation in health, disease and
development. The genome adopts discrete structural and regulatory domains that are maintained across cell
types and even organisms. However, while it is becoming clear that alterations in this standard topology play
important roles in both development and disease, very little is known about the mechanisms that dynamically
control the restructuring process. Moreover, it is unknown whether (or how) the topology of the genome
contributes to the coordination of expression of genes critical to the cell’s response to stress.
We have established a system in which we can
induce dramatic architectural rearrangements
concerted within and between genes and
synchronized across a population of cells. The
system, the heat shock response in the budding yeast
S. cerevisiae, allows us to leverage the powerful
genetic tractability of this organism to define the
factors and uncover the mechanisms that drive
genome architecture and nuclear reorganization.
Moreover, Heat Shock Protein (HSP) genes and the
transcriptional regulator that controls their expression,
Heat Shock Factor 1 (Hsf1), are evolutionarily
conserved and critical for health and disease. Using a
highly sensitive and quantitative version of
chromosome conformation capture (3C) that our
laboratory developed, termed Taq I - 3C, we have obtained evidence that in response to acute thermal stress,
HSP genes undergo intense intragenic interactions that include looping between UAS and promoter elements,
promoter and terminator regions and regulatory and coding regions. Even more striking, they engage in
frequent intra- and interchromosomal interactions, coalescing into discrete intranuclear foci. Genes that are
heat shock-activated by an alternative transcription factor (TF), Msn2, likewise loop yet do not appear to
coalesce, either with themselves or with Hsf1-target genes. Likewise, robustly transcribed, constitutively
expressed genes undergo intragenic looping yet these genes too do not appear to coalesce. In addition to their
distinctive coalescence, the intragenic and intergenic restructuring/reorganization of Hsf1-target genes is
remarkably dynamic: detectable within 60 sec, peaking within 2.5 min and attenuating within 30 min. These
observations raise important questions. To address these, we propose three aims:
Aim 1: Elucidate the 3D topology of the yeast genome during heat shock and other stresses, and the
role played by Hsf1 and Pol II in orchestrating these changes. We will utilize cutting-edge deep
sequencing-based approaches, principally Taq I – Hi-C, to reveal heat shock- and factor-dependent
chromosomal topology dynamics across the genome. We will define the role of Hsf1 and the Pol II, and other
factors identified in Aims 2 and 3, in driving 3D genome architecture in cells exposed to thermal stress. We will
confirm key findings using Taq I - 3C.
Aim 2: Elucidate determinants of Pol II and Hsf1 in driving HSP gene coalescence and test notion that
HSP condensates assemble through liquid-liquid phase separation. We will identify the functional
domains within Hsf1 and Pol II that are responsible for driving HSP genes into coalesced foci in cells exposed
to acute HS, and explore the biophysical nature of the dynamic HSP condensates.
Aim 3: Unveil the roles of transcriptional coactivators, chromatin remodelers and architectural proteins
in driving the specific and dynamic interactions within and between Hsf1-target genes.
We will test that hypothesis that HSP gene coalescence represents the concerted action of multiple cofactors –
recruited by Hsf1 and acting in concert with Pol II – and investigate the contribution made by select factors,
focusing on those that are preferentially recruited to HSP genes in coalescence-competent cells. We will
exploit the Taq I-3C assay in combination with an array of powerful yeast genetic techniques – conditional
nuclear depletion, conditional protein degradation, genome-editing – to interrogate the role of these factors.
Together, the experiments proposed will reveal both mechanistic insight and a broad, genome-wide
perspective on the dynamic, Hsf1-dependent 3D genome remodeling that occurs during the yeast heat shock
response. They will set up a future exploration of the biological significance of HSP gene coalescence,
informed by results of experiments proposed here.

Public health relevance
PI: David S. Gross, Ph.D. GM138988 Research Strategy I outline below the experiments dependent on qPCR that are required to complete the project. Aim 1. Elucidate the yeast interactome and characterize the roles of Hsf1 and RNA Pol II in sculpting 3D genome architecture in response to heat shock. 1.1. Use a genome-wide approach – SPRITE, Micro-C, Taq I-Hi-C or Hi-ChIP – to reveal the heat shock-dependent yeast interactome. Verification of genome-wide analyses using targeted Taq I - 3C. A key remaining objective of this project is to characterize the 3D remodeling of the yeast genome that we hypothesize occurs in heat- or chemically stressed yeast cells. While the principal techniques will rely on next-generation sequencing methodology, verification of select genomic interactions will require Taq I - 3C. In this technique, a highly sensitive and quantitative version of the original 3C method (Dekker et al., 2002) that we developed (Chowdhary et al., 2020), qPCR underlies the quantification. 1.2. Define the role of Hsf1 and Pol II in driving 3D genome architecture in cells exposed to thermal stress. Similar to above; here the specific role of two proteins – Hsf1 and Pol II – in driving 3D conformational changes in the genome will be assessed. Verification of key intergenic / chromosomal loci interactions obviated by prior depletion of either of these two proteins will be performed using Taq I - 3C. AIM 2: Define the role of Hsf1 binding sites and functional domains within Hsf1 that underpin its ability to dynamically drive members of its regulon into condensates. 2.1. Test the role of Hsf1 binding sites (Heat Shock Elements; HSEs) – as well as HSP structural genes themselves – in driving HSP gene coalescence. Taq I-3C will be used to analyze (and quantify) the role of select HSEs and structural genes in fostering the interactions between the remaining HSP gene cohort. 2.2. Identify the functional domains within Hsf1 that are responsible for driving HSP genes into coalesced foci in cells exposed to acute HS. As above, Taq I-3C will be used to quantify the role of specific functional domains within Hsf1 using well-characterized HSP gene loci in the analysis. 2.3. Perform RNA-seq on the hsf1-ΔNTA mutant. RT-qPCR will be used to validate the expression of select HSP genes whose transcript abundance is impacted by deletion of the Hsf1 N-terminal activation domain as suggested by RNA-seq. PI: David S. Gross, Ph.D. GM138988 2.4. Identify the role of the Pol II CTD, and in particular, its phosphorylation state, in driving HSP genes into coalesced foci in cells exposed to acute HS. As in 2.1 and 2.2, Taq I - 3C will be used. AIM 3. Test the role of Mediator and other cofactors in driving HSP gene coalescence (HGC). 3.1. Test the contribution of ATP-dependent chromatin remodeling complexes – in particular, Ino80C and Swr1C, implicated in triggering movement of transcriptionally activated genes within the nucleus – in driving HGC. As in 2.1 and 2.2, Taq I - 3C will be used. We will also conduct ChIP-qPCR analyses of the catalytic subunits of the two CRCs - Ino80 and Swr1, respectively, testing the hypothesis that heat shock induces recruitment of Ino80 to Hsf1-target genes while it simultaneously causes dissociation of Swr1. This in light of our preliminary observations which suggest that Ino80 promotes, while Swr1 suppresses, HGC. 3.2. Test the role of the architectural proteins, cohesin and condensin, in driving HGC. Taq I - 3C will be used to interrogate the role of cohesin (in particular, its essential subunits Scc1 and Pds5) and condensin (in particular, its essential subunit Brn1) on 3D repositioning. We will also conduct a Scc1 ChIP-qPCR analysis testing the hypothesis that those loci most extensively involved in 3D restructuring of the genome in HS-induced cells are preferentially occupied by cohesin. 3.3. Test the role of Mediator in driving HGC. We plan to evaluate the impact of mutations within the N-terminal half of Mediator Tail subunit Med15 at the transcriptional, Mediator (Med17) occupancy and chromatin interaction levels using RT-qPCR, ChIP-qPCR and Taq I-3C assays, respectively. 3.4. Test the role of components of the nuclear pore complex (NPC) in facilitating HSP gene transcription and gene coalescence. RT-qPCR ChIP-qPCR and Taq I - 3C assays will be employed to interrogate the role of NPC proteins in driving the formation of HSP gene clusters in heat shock-induced cells. Our preliminary results indicate a dichotomy of function: those Nups (e.g., Nup1 and Nup145) whose role is restricted to functions of the nuclear pore complex itself do not appear to affect HGC while those Nups that have both NPC and NPC-free (freely diffusing) roles (e.g., Nup2 and Mlp1) do impact HGC.